Wake Forest NCORP Research Base

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Public health relevance
The Wake Forest NCORP Research Base develops and implements multi-site Cancer Control and Cancer Care Delivery (CCDR) clinical research studies in partnership with NCORP Community and Minority/Underserved Community Sites to improve patient well-being and the quality of cancer care.